All of Us Consortium of CTSA Community Engagement Programs

The All of Us University of Florida Program works with the All of Us NIH team towards Program Strategic Goal #4: Researchers on the Workbench. Under this Goal, in year 4 we are pursuing five milestones. Firstly, we will test the All of Us Curriculum that our team developed in Year 3 to cover the three tiers (Public, Registered and Controlled) and Researcher Workbench features, along with specific medical condition Use Cases of concern to communities in the United States: Cancer, Depression, Diabetes, Hypertension, and the Consequences of Cannabis Use. Next, we will evaluate and refine the All of Us Curriculum with the assistance of other All of Us partner sites and the Association for Clinical and Translational Science volunteers from across the country. Additionally, we will assist the NIH as subject matter experts with the curriculum which may require reviewing new data types, features, and functionalities within the Researcher Workbench, providing feedback on emerging initiatives, and pilot testing new products for researchers. We will continue to work closely with our NIH Program Officer and funded partners within the timeline to maximize the full potential of the All of Us Research Program and Researcher Workbench to advance precision medicine.

Public health relevance
The public health relevance is to return value to the public by expanding researcher training and use of the Workbench and by improving researcher understanding of how to access and analyze the data from the participants of the All of Us Program, including their biomarker data, electronic health data, and survey responses to understand risk and protective factors for both rare and common conditions that affect the US population for better prevention and health interventions.